Examining the Mechanisms Underlying the Influence of Facebook Food Advertisements on Adolescents' Eating Behaviors: Randomized Controlled Trials

Project Summary
Poor diet and excess weight during adolescence predicts excess weight and diet-related cancers during
adulthood, yet there is little research on the risk factors that contribute to weight gain among adolescents. The
National Academy of Medicine identifies exposure to food advertisements (ads) as a major predictor of poor diet
among children (<12 years of age) because studies have shown that children who are exposed to food ads
consume more calories than children who are exposed to non-food ads. The few food ad studies that have
included adolescents (13–17 years of age) found associations between self-reported exposure to television (TV)
food ads and poor diet, but we do not know which mechanisms explain this relationship. It is also well established
that food companies promote their least healthy products to Black consumers more than White consumers and
perceive Black youth as trendsetters. But it is not known whether seeing racially congruent ads (i.e., the person
in the ad and the viewer are the same race) places Black adolescents at higher risk of poor diet relative to Whites.
Finally, most food ad research is based on TV ads, but food companies are increasingly targeting adolescents
on social media. And no social media food ad studies have focused on racially targeted ads. Addressing these
gaps is important because adolescence is a critical period for adopting nutritious eating habits that can prevent
future diet-related cancers. The overall objective of our three studies is to identify the extent to which exposure to
Facebook food ads increases the number of calories purchased and consumed by Black and White adolescents.
Guided by strong preliminary data, we will test three aims: 1) To evaluate the extent to which exposure to racially
congruent vs. incongruent Facebook food ads causes Black vs. White adolescents to purchase more calories for a
snack; 2) To determine the extent to which exposure to many vs. few “likes” on Facebook food ads causes Black and
White adolescents to purchase more calories for a snack; and 3) To test the degree to which visual attention to
unhealthy foods, racially congruent people, and/or “likes” in Facebook ads explains the relationship between ad
exposure and calorie intake. To address the first and second aims, we will conduct two randomized online
experiments. Under the third aim, we will conduct a within-subjects lab study using eye-tracking technology. We
hypothesize that exposure to racially congruent Facebook food ads will increase the number of calories
purchased and consumed by adolescents. We also predict that Black adolescents who attend to Black people
in food ads will consume more calories than those who attend to other ad features. This innovative work will
examine actual purchases and caloric intake; use novel tools (e.g., Facebook “reaction” buttons) to examine ad
preferences; and use a state-of-the-art eye-tracking computer with discreet cameras. The proposed research
will increase our mechanistic knowledge of communication tools that influence adolescents' dietary behaviors and
could inform cancer prevention interventions that aim to improve adolescents' diets using effective ad techniques.

Public health relevance
Project Narrative This proposal is relevant to public health and cancer prevention because it will provide comprehensive data on the influence of Facebook food advertisements on Black and White adolescents' eating behaviors, and increase mechanistic knowledge of communication strategies that influence the number of calories purchased and consumed by adolescents. Once such knowledge is gained, there is potential for significant advances in the development of interventions seeking to establish lifelong cancer-prevention dietary habits among adolescents. The project is relevant to the mission of the National Cancer Institute because it aims to identify factors in the new media ecosystem that may contribute to behaviors that increase risk for diet-related cancers, and it provides a new framework for understanding how the participatory social media ecosystem affects cancer prevention behaviors among youth who are targeted with unhealthy food and beverage advertisements.